Advancing Conformance with the VNRFRPS in Indiana

Indiana State Department of Health RFA-FD-12-01 PI: Scott Gilliam Advancing Conformance with VNRFRPS Project Summary/Abstract This funding opportunity will allow Indiana to contribute to a nationally integrated food safety system by attaining full conformance with the Voluntary National Retail Food Regulatory Program Standards (VNRFRPS) over the next five years at the state level and assist local health departments in Indiana with enrollment and implementation of the VNRFRPS. Marketing efforts will focus on creating a culture where retail standards are identified as a priority by promoting their public health significance. The ISDH FPP will contribute to the upcoming 2013 Public Health Accreditation Application to ensure the Center for Disease Control and Prevention's 10 Essential Services are being met by the agency. Conformance with VNRFPRS will align with the ISDH mission to promote and provide essential public health services to protect Indiana communities in the planning, delivery, and evaluation of public health services and is considered as equivalent to this accreditation by the Public health Accreditation board. Solutions to the nine VNRFRPS Standards will be carefully evaluated for duplicability and as efficient and innovative models for other retail regulatory bodies both at the local and national level. Conformance with these program standards will help Indiana contribute to Federal and other State Programs to better direct regulatory activities at reducing foodborne illness hazards in retail facilities. Compliance with the standards translates to greater capability to respond via established relationships with other partners with the food industry, academia, and epidemiology groups. The Standards require the goals and objectives to be date driven, so the electronic CodePal data collection and inspection management system will be expanded. 1

Public health relevance
Project Narrative: ISDH developed its 5 year plan for 2011 - 2016, the Indiana State Health Improvement Plan (I- SHIP) which includes:"Assure Food Safety" as a top priority. This can be accomplished through education and working toward compliance with the Food and Drug Administration (FDA) VNRF RPS. This funding would allow the ISDH FPP attain compliance with the Standards and the 10 Essential Services to have direct influence on public health in the nation and significantly impact the health of Hoosiers. 1 __SpecificAimsTextDelimiter__ Indiana State Department of Health RFA-FD-12-01 PI: Scott Gilliam Advancing Conformance with VNRFRPS Specific Aims Goal - The Indiana State Department of Health (ISDH), Food Protection Program (FPP) Contributes to a nationally integrated food safety system by achieving and then maintaining conformance with the Voluntary National Retail Food Regulatory Program Standards (VNRFRPS) by September 30, 2017 which will provide the ISDH FPP a direct influence on public health in the nation and significantly impact the health of Hoosiers by reducing foodborne illness related retail food establishments. Outcomes - ISDH FPP conformance with the VNRFRPS will dramatically improve outcomes such as targeted risk based inspections and intervention strategies, adequately trained inspectors, improved relationships with stakeholders, improved response and preparedness capabilities and coordination with state and national programs, and data driven goals and objectives. It is anticipated that conforming to the VNRFRPS will directly relate to the decrease in negative food safety occurrences. Objectives - " A VNRFRPS coordinator will be hired to facilitate conformance with the VNRFRPS by using the baseline assessment completed in 2009 (recent enhancements reported in 2012) and the 2010 Indiana Local Health Department Assessment of Retail Activities where LHD conformance was evaluated, to identify and prioritize all gaps in VNRFRPS at the State level. " Develop state policies to ensure uniformity with VNRFRPS. " Provide training and assist LHDs to conduct inspections and surveillance of retail food facilities based on revised state policies. " In 2013, begin revisions of Indiana Rule 410 IAC 7-24, Retail Food Establishment Sanitation Requirements to the 2009 FDA Food Code and 2011 Supplement. " Conduct a marketing campaign directed to Health Officers and Administrators in coordination with the ISDH Public Affairs and Local Liaison Programs, to promote as a priority enrollment in VNRFRPS. " Completion of the ISDH FPP Public Health Accreditation through the Public Health Accreditation Board " Completion of the Indiana State Health Improvement Plan (I-SHIP), Assure Food Safety Priority, strategies, and outcomes that corresponds with accreditation and the VNRFRPS. " Finish and roll out the FPP electronic data collection and inspection program called CodePal , so that the local health departments, food industry and the public can begin using the system and drastically improve the data of food establishments, including demographic, complaints, outbreak reports, sample, licensure/registration and inspection data. " Coordinate training activities regarding VNRFRPS with FPP training specialists. 1